Improving Analgesic Effectiveness and Safety with Proactive Precision Pain Management in Thoracic Surgical Patients with Lung Lesions

PROJECT SUMMARY
Thoracic surgery (TS), especially pneumonectomy, lobectomy and segmentectomy, are common and very
painful surgeries for lung lesions with high incidence of uncontrolled acute surgical pain, chronic post-
thoracotomy pain and excessive opioid use. Those with poorly controlled acute surgical pain are at risk for
chronic post-surgical pain (CPSP), long-term opioid use and opioid addiction. One third of patients undergoing
minimally invasive thoracic surgery and one-half undergoing thoracotomy will develop chronic post-surgical pain.
TS patients are the least likely to be receiving opioids before surgery, yet they have the highest rate of new
persistent opioid use after TS compared with other surgical cohorts. Current best practice postoperative pain
management includes standardized enhanced recovery after surgery (ERAS) multimodal analgesic approaches
that consist of a combination of opioids and non-opioids with the goal of minimizing opioids during and after
surgery. While ERAS protocols have reduced immediate perioperative opioid use, they follow a “one size fits all”
trial-and-error reactive protocol approach of standardized analgesic selection at the discretion of physicians, and
at-risk patients continue to experience uncontrolled pain, CPSP, costly opioid-related AEs, and poor long-term
outcomes. Current evidence shows that 30-60% of interindividual responses to opioids are influenced by genetic
factors, with demographic and clinical attributes adding additional risk factors. OpalGenix will build on our
extensive prior prospective studies of genetic and clinical predictors of postoperative pain, CPSP, and opioid-
related adverse outcomes to develop and commercialize OpalGenix’s Genotype-guided Physician Support for
Analgesics use, GPS-AnalgesicsTM. GPS-Analgesics will be a pre-operative 510(k) cleared predictive analytic
software as a medical device consisting of preoperative genotyping and electronic health record-integrated
intelligent analytics to provide personalized risk analysis to proactively predict risk for surgical pain and opioid
responses, supporting clinical decision for optimal and safe personalized post-TS pain management. Phase I
will confirm accuracy of risk prediction for a combination of multiple biologically relevant candidate genes in 200
adult TS patients in a prospective longitudinal study and develop risk prediction algorithms that innovatively
integrate polygenetic and clinical risks (e.g. depression, anxiety, catastrophization) to predict personalized risk
for acute surgical pain, inpatient opioid use, CPSP, opioid-induced RD, PONV, excessive sedation, longer
hospital stays, persistent opioid use, high cost of care, and opioid dependence. Successful completion of Phase
I will demonstrate that OpalGenix’s proprietary, multi-factorial approach to risk prediction has clinical utility in TS
patients and will position OpalGenix to submit an IDE application to the FDA for a head-to-heal clinical trial for
Phase II. GPS-Analgesics will provide evidence-based risk assessments for personalized ERAS protocols that
will enhance surgical pain relief, eliminate CPSP while avoiding opioid-related safety risks.

Public health relevance
PROJECT NARRATIVE Thoracic surgeries are one of the most painful and common surgeries that are frequently associated with uncontrolled acute surgical pain, excessive hospital and long-term opioid use, and high-risk for chronic post- surgical pain. Each individual responds differently to surgical pain and analgesics based on their unique genetic and clinical risk factors, and the current trial-and-error reactive approach to post-surgical pain management and opioid prescribing results in uncontrolled severe surgical pain, chronic persistent surgical pain, excessive opioid use, and costly adverse opioid and pain-related outcomes. OpalGenix is developing a preoperative genotype and clinical factors based robust and reliable risk predictive algorithms implementable in electronic health record that will proactively assess these personalized risks following thoracic surgery to maximize surgical pain relief while eliminating safety risks and costly adverse postoperative outcomes.